Multidisciplinary electronic consultation to improve evidence-based care for patients with diabetic kidney disease

PROJECT SUMMARY/ABSTRACT
Diabetic kidney disease (DKD) is the leading cause of end stage kidney disease (ESKD). Despite evidence that
sodium-glucose cotransporter-2 inhibitors (SGLT2i) and renin and angiotensin system inhibitors (RAASi) can
reduce of risk of ESKD in patients with diabetes, prescription rates remain low. This R03 proposal is responsive
to SEN NOT-HS-19-011: Health Services Research Priorities for Achieving a High Value Healthcare System
which specifically addresses “transforming kidney care” and “reinventing primary care.” The goal of this study
is to finalize and assess the implementation and preliminary effectiveness of the Multidisciplinary
Diabetic Kidney Disease Program (MDKDP), a population health strategy developed at Montefiore, to
assure evidence-based care for patients with DKD. MDKDP is designed to overcome known barriers to
prescribing RAASi and SGLT2i by primary care providers (PCPs) for patients with high-risk DKD. MDKDP is
composed of three implementation strategies: 1) a dashboard of patients with high-risk DKD (High-risk DKD
Dashboard) allowing the proactive targeting of patients not receiving evidence-based treatment, 2)
multidisciplinary collaboration between endocrinologists, nephrologists and PCPs, and 3) use of a novel
population health strategy where endocrinologists and nephrologists initiate contact with PCPs using an
electronic consultation (e-consult) for patients with treatment gaps identified on the High-risk DKD Dashboard.
The content of the MDKDP e-consult will be customized for individual patients and include recommendations for
use of RAASi and/or SGLT2i and modification of currently prescribed diabetes and hypertension medications.
There are three potential outcomes following a MDKDP e-consult: 1) PCP-initiated change in treatment, 2) PCP
request for co-management through a patient appointment with the specialist team or 3) no changes. The specific
aims of this proposal are 1) to finalize MDKDP by identifying the factors which may affect the implementation of
MDKDP and actionable recommendations for modifying the implementation strategies and 2) to assess the
implementation outcomes of adoption, acceptability, appropriateness and feasibility and evaluate preliminary
effectiveness defined as PCP-initiated change in SGLT2i and/or RAASi prescription or request for co-
management. We will perform qualitative analysis of focus groups with physician stakeholders to finalize
MDKDP, pilot test MDKDP for 20 PCP-patient pairs, and perform qualitative analysis of interviews with pilot trial
participants. This R03 will allow the study team to rigorously evaluate MDKDP to assess the degree to which it
is successful in implementing evidence-based treatments for a population at high risk for progression to ESKD.
Based on outcomes, the research team will prepare a future, large RCT designed to scale the intervention and
evaluate patient outcomes including blood pressure, hemoglobin A1C, and DKD progression. MDKDP is
generalizable to U.S. institutions experiencing gaps in evidence-based treatments for DKD and the use of e-
consults for population health management can be adapted to other high yield evidence-based practices.

Public health relevance
PROJECT NARRATIVE Many patients with diabetic kidney disease are not prescribed medications that can reduce the progression to end stage kidney disease. The proposed research will 1) develop the Multidisciplinary Diabetic Kidney Disease Program, in which diabetic kidney disease specialists will proactively provide recommendations to primary care providers about patients who would benefit from these medications and 2) test if the program can be implemented at a health system to increase prescribing of these medications. The results of this study will inform strategies to improve care for patients with diabetic kidney disease.